Annual Meeting of the Society for the Study of Reproduction

Project Summary
The Society for the Study of Reproduction (SSR) holds an annual scientific meeting
attended by ~900 basic and clinical researchers, teachers, and undergraduate,
graduate, and postdoctoral trainees, from universities, medical schools, research
institutes, and clinics in the U.S. and more than 30 other countries. The three-fold goals
of every meeting are (1) to present state-of-the-art research in the biology underlying
and associated with reproduction, fertility, and development; (2) to provide an
environment that encourages scientific dialogue, collaboration, and innovation and (3) to
provide a meeting program, setting, and culture that promotes inclusiveness and
professional development of trainees and early-stage investigators. Each meeting
consists of plenary and state-of-the-art lectures by world-class scientists, and 20-25
concurrent sessions (with 2-4 speakers in each) over 3 and a half days that focus on
subjects of interest to scientists in biomedical, clinical, and veterinary and animal
science, as well as those who concentrate on wildlife conservation. Oral and poster
presentations (typically 50-100 and 500-600, respectively) highlight research
contributions by scientists from a range of career stages, but with a special focus on
trainees and early career investigators. These presentations are selected from
submitted abstracts, based on quality review by the Program Committee. Abstracts
submitted for trainee award competitions also are reviewed by the SSR's Awards
Committee. This grant application is a renewal of our longstanding SSR annual meeting
grant and will support the SSR Annual meetings in 2023 (Ottawa, CA), 2024 (Dublin,
IE), sites for 2025-27 are yet to be determined.

Public health relevance
PROJECT NARRATIVE The SSR annual meeting provides a venue, scientific program, and environment designed to stimulate learning and collaboration and engage attendees in critical scientific discussion with the goal of generating new knowledge leading to solutions in reproductive medicine, public health, agriculture, and conservation that will benefit humans and animals. A critical goal of our meeting is to enhance training and mentoring of a diverse cohort of trainees and support them as they progress through their careers.